Locus Coeruleus Imaging Markers in Preclinical Alzheimers disease, Cerebrovascular Disease and Cognitive Decline

Project Summary
The proposed study will investigate brain imaging markers of a small brainstem nucleus called the locus
coeruleus, which is important for cognitive function and is the first brain region to show Alzheimer’s disease-
related changes in older adults who go on develop dementia. The study will examine brain imaging locus
coeruleus markers in older adults who go on to have a healthy aging experience over time and in those who go
on to develop Alzheimer’s disease, cerebrovascular disease and cognitive decline. By comparing the trajectory
of changes in brain imaging markers of the locus coeruleus, we can better understand the potential value of
these imaging markers for tracking disease progression from a very early stage.

Public health relevance
Project Narrative The proposed studies will investigate brain imaging markers of the locus coeruleus, a key brain region underpinning cognitive function impacted very early in Alzheimer’s disease, and will determined whether locus coeruleus markers are predictive of Alzheimer’s disease, cerebrovascular disease and cognitive decline in older adults.